CALCIUM HOMEOSTASIS AND BONE MINERAL DENSITY IN YOUNG FEMALES WITH HIV INFECTION

Volunteers will be recruited from girls attending the IPC clinic. We will only recruit female children as calcium metabolism & bone growth is of special concern in females & we only have control data on calcitropic hormones & bone mineral density in female children. There are currently approximately 81 HIV-infected children between the ages of 5-17 years who receive care in the IPC clinic. Given excellent participation in previous nutrition related protocols, we anticipate that we should achieve a sample size of 20 females in this age group. Over 90% of the HIV-infected children are African-American. All data collected will be compared to age & race matched girls as calcipropic hormones, bone density & calcium kinetics significantly differ between black & white girls.